Spleen Tyrosine Kinase Inhibition to target Neutrophil Extracellular Traps in Severe Persistent Asthma

PROJECT SUMMARY
Puerto Rico, a United States (U.S.) territory, has the highest asthma rates globally, with 14.2 percent of its
residents affected at some point. They are more likely to be hospitalized and four times more likely to die from
severe asthma compared to any other group in the U.S. Asthma affects 334 million people worldwide, including
7 million children, and is a heterogenous obstructive airway disease, with severe cases accounting for over 50%
of its healthcare costs. Severe asthma is characterized by high levels of neutrophil infiltration leading to airway
inflammation. The persistent gaps in understanding the immune responses and molecular networks contributing
to severe asthma hinder the development of innovative and effective treatments. Usually, cellular inflammation
of the airways is driven by eosinophils or neutrophils. The study focus is the neutrophilic asthma subgroup, which
accounts for 20 – 30% of all cases. It is characterized by severe and persistent disease, frequent exacerbations,
and hospitalizations. Neutrophils play a crucial role in innate immune responses and inflammation through
phagocytosis, degranulation, the release of reactive oxygen species, and the release of neutrophil extracellular
traps (NETs). Excessive NETs production without an infection leads to inflammation, cellular damage, and organ
failure. NETs formation has emerged as a crucial mechanism contributing to asthma pathogenesis via different
mechanisms. Thus, supporting the premise that targeting NETs production is a feasible therapeutic target for
severe asthma. Spleen Tyrosine Kinase (SYK) is essential for neutrophil activation and the production of NETs.
In neutrophilic animal models, SYK inhibition has improved outcomes and reduced airway inflammation.
Intriguingly, SYK has been shown to play a role in NETs release and to promote better outcomes in animal
models. The central hypothesis is that SYK signaling mediates NETs formation in severe asthma, contributing
to the disease’s pathogenesis. The proposed project is of utmost importance as it addresses a pressing and
relevant issue in asthma. By characterizing unique populations and conducting functional assays on primary
human neutrophils, we will gain new insights into the underlying mechanisms driving severe asthma. The
translational relevance of this study is that it will convey fundamental knowledge from human samples to support
future clinical trials examining SYK inhibition to complement and improve current asthma management. The
research program is based at the highly regarded Ponce Health Sciences University, a Puerto Rican academic
institution with a strong clinical research platform focused on addressing health disparities. The principal will be
led by two foremost experts in the field. Principal investigators of this study, Marcos J. Ramos-Benitez, PhD, and
Wilfredo De Jesús-Rojas, MD, FAAP, MSc, are experts renowned for their expertise in neutrophil biology and
clinical and translational pulmonary medicine, respectively. The research program is prepared to complete the
planned project on schedule and with the highest data quality and management. The team is well-suited and
equipped for recruiting individuals with chronic severe asthma and collecting biological samples and clinical data.

Public health relevance
Severe asthma is a major public health concern associated with high rates of hospitalization, healthcare utilization, and reduced quality of life. This project seeks to improve understanding of the immune mechanisms that contribute to severe asthma by examining the role of neutrophil extracellular traps and Spleen Tyrosine Kinase (SYK) signaling in airway inflammation. By identifying biological pathways that drive severe disease, this research will generate knowledge to support the development of new therapeutic strategies and inform future clinical studies aimed at improving health outcomes for individuals affected by asthma.